Exploring the etiology of oxidative damage and cell death in placental malaria

Abstract
Malaria is a major public health problem for many regions of the world, affecting mainly pregnant women and
young children. Plasmodium falciparum infection during pregnancy results in significant fetal compromise and
contributes to hundreds of thousands of infant deaths each year. These outcomes are associated with a
number of malaria-induced placental pathologies, including infiltration of maternal inflammatory cells into the
placenta in response to the infection. This, in turn, is linked to significant damage to the villous placenta,
including necrotic death of syncytiotrophoblast. Complete understanding of the critical cellular and molecular
mechanisms that drive placental damage and dysfunction in placental malaria, however, remains elusive.
Evidence suggests that neutrophils and monocytes accumulate in inflammatory placental malaria, and
neutrophils in particular are also implicated in severe malaria in non-pregnant patients. However, few details of
the roles of these cells in placental malaria pathogenesis are available. Motivated by exciting preliminary data
that show profound lipid peroxidation in placental malaria, we hypothesize that activated innate immune cells,
through oxidative mechanisms, directly contribute to syncytiotrophoblast stress and death in placental malaria,
thereby precipitating poor birth outcomes via placental dysfunction. The objective of this application is to
address this hypothesis using placenta tissue from a malaria endemic population, villous explants and a mouse
model that recapitulates key aspects of placental malaria.
The study objectives will be achieved through three Specific Aims. First, preserved placental tissues from
Kenyan women exposed to malaria will be assessed by spatial transcriptomics to establish the extent to which
trophoblast oxidative stress and necroptosis are coincident in natural infection. Second, the impact of
trophoblast exposure to activated neutrophils and monocytes will be characterized in an in vitro simulation of
placental malaria. Oxidative damage, necroptosis and other cell death mechanisms, and syncytiotrophoblast
destruction will be monitored in villous explants exposed to neutrophils and monocytes undergoing respiratory
burst. Third the role of neutrophil and monocyte oxidative burst, and the relative role of pro-oxidant malarial
hemozoin, in driving placental oxidative stress and damage will be investigated in an outbred mouse model for
placental malaria. Successful completion of this research will expand understanding of the mechanistic basis of
malaria-induced placental damage and fetal compromise, leading to identification of new targets for adjunctive
therapies in malaria during pregnancy. By advancing fundamental knowledge of mediators of
syncytiotrophoblast compromise and death, this work will have implications for other pregnancy conditions
associated with maternal monocyte and neutrophil activity, placental oxidative damage, and cell death-related
placental dysfunction.

Public health relevance
Project Narrative Although it is clear that placental damage and dysfunction underlie poor birth outcomes associated with maternal malaria infection, the cellular and molecular mechanisms that underlie this damage remain very poorly understood. Exploration of these mechanisms, in particular the role of innate immune cell-driven oxidative stress in mediating placental cell stress and death in malaria, could contribute to the development of improved interventions that would reduce poor birth outcomes in malaria and other pregnancy complications that share these pathogenic features.